Probing the mechanisms of dependency underlying skeletal genetic pathways of p53 and Notch in the pathogenesis of osteosarcoma

Project Summary
The goal of this proposal is to understand cancer dependency pathways that regulate premalignant osteoblasts
and the development of osteosarcoma. Osteosarcoma originates from cells of the osteoblast lineage and is a
fatal bone tumor that occurs primarily in children. Clinical outcomes for human osteosarcoma patients with tumor
recurrence or metastatic spread are devastating. Elucidating cancer-dependent skeletal genes and pathways in
osteosarcoma is critical for the development of effective new therapies. Multiple lines of evidence indicate that
tumor protein p53 and Rb mutations are major drivers of osteosarcoma in patients with Li-Fraumeni family cancer
syndrome and hereditary retinoblastoma, as well as in the majority of patients with sporadic osteosarcoma.
However, how dependent genes and pathways in osteosarcoma promote proliferation, differentiation, and
metastasis is unclear. We have recently developed several osteoblast-specific genetically engineered mouse
models (GEMMs) of osteosarcoma tumors that recapitulate the defining features of human osteosarcoma,
including cytogenetic complexity, gene expression signatures, histology, and metastatic behavior. These models
provide powerful tools for understanding the above clinical challenges and developing new treatment strategies.
Our preliminary studies in mouse and human osteosarcoma cells uncover a link between cancer-dependent
pathways and osteosarcoma progression. Validation of these findings will greatly facilitate clinical applications.
Based on these findings, we hypothesize that cancer-dependent skeletal genes and pathways play critical roles
in osteosarcoma progression. Furthermore, perturbation of cancer-dependent pathways may contribute to
osteosarcoma metastasis and cancer therapy. We will test this hypothesis through two specific aims. 1)
Investigating the role of cancer-dependent skeletal genes and pathways in osteoblast-specific p53 and Rb loss-
of-function models; 2) Assessing the potential for manipulation of cancer-dependent skeletal genes and
pathways to treat GEMMs as well as human osteosarcoma xenograft models. As this work is completed, we will
have a more complete understanding of the molecular mechanisms underlying the role of cancer-dependent
skeletal pathways in osteosarcoma growth and progression. Additionally, we will gain improved rationales for
the use of preclinical and/or clinical agents in pediatric cancer treatment, as well as new insights into how to
improve the efficacy of chemotherapeutic agents.

Public health relevance
PROJECT NARRATIVE Understanding the operation of cancer drivers in tumorigenesis has significant implications for enhancing human health and disease treatment. Specifically, acquiring fresh understanding and perspectives on the involvement of cancer dependency genes and pathways in osteosarcoma growth and spread will be essential. The project seeks to apply these discoveries to support the creation of precise targeted treatments for childhood cancer.